Acquisition of a Cypher VRS Video-Rate Atomic Force Microscope System

Project Summary/Abstract This in an application for funds to enhance the atomic force microscopy capabilities of the Materials Characterization Laboratory (MCL) at The Pennsylvania State University by purchasing a Cypher VRS (Video-Rate System) Atomic Force Microscope (AFM) from Asylum Research (Oxford Instruments). The Cypher VRS AFM is capable of label-free, high-speed, high-resolution topography scanning including multi-mechanistic parameter surface analysis designed for a broad range of biological samples. This instrument is capable of providing nanometer-scale-resolution at high-speed scan rates that permits real-time observation and quantification of a variety of highly dynamic biological processes at the single molecule level. The MCL currently houses a Bruker Bioscope Resolve AFM that is designed for both dry and wet samples, but is limited to scan rates of ~10-20 lines/second. In contrast, the Cypher VRS AFM instrument can scan up to 625 lines/second, thus enabling the visualization of dynamic structural changes and dynamic interactions occurring within or between individual molecules or macromolecular assemblies occurring with rate constants approaching 10/s. Eleven investigators, supported by sixteen grants from NIH, will benefit from addition of the Cypher VRS AFM to the MCL.

Public health relevance
Project Narrative The NIH-funded projects that will benefit from the purchase of the Cypher VRS (Video-Rate System) Atomic Force Microscope (AFM) focus on many fundamental areas of biology, including virus entry, virus replication, eukaryotic gene regulation and expression, RNA processing, RNA splicing, translation, motility, cytoskeletal transport, and the genetics of developmental patterns and morphological changes. The acquisition of this instrument will have a substantial impact on the understanding of the dynamics of macromolecular assemblies contributing to these processes. This knowledge may contribute to the prevention, diagnosis, and/or treatment of myriad diseases afflicting citizens of the United States.